Combinatorial design of nonviral base editing systems for treating cystic fibrosis with nonsense mutations

PROJECT SUMMARY
Cystic fibrosis (CF) is a debilitating genetic disorder that predominantly impacts the lungs and pancreas due to
mutations in the cystic fibrosis transmembrane conductance regulator (CFTR) gene. Specifically, nonsense
mutations, which produce truncated, non-functional proteins, account for approximately 11% of all CF cases.
Currently, these mutations lack targeted, effective therapeutic solutions. Our research endeavors to address this
unmet clinical need by harnessing the capabilities of adenine base editors (ABEs) to correct premature
termination codons (PTCs) through translational readthrough, thereby restoring functional protein expression.
To facilitate efficient delivery, we aim to formulate lipid nanoparticles (LNPs) specifically engineered for
pulmonary ABE delivery. The project is segmented into three pivotal objectives: 1) the chemical refinement of
RNA-encoded ABEs to achieve optimal on-target gene-editing; 2) the development and fine-tuning of LNP
formulations to overcome challenges intrinsic to pulmonary delivery; and 3) comprehensive in vivo validation
using a CFTR nonsense mutation mouse model to assess both therapeutic efficacy and safety profiles. By
focusing on nanoparticle-mediated lung cell engineering, our approach lays the foundation for a groundbreaking,
non-viral base editing platform that could revolutionize treatment protocols for CF and other diseases stemming
from PTCs. Employing cutting-edge methodologies, including the optimization of mRNA sequences encoding
ABEs, gRNA design, and novel four-component combinatorial lipid chemistry, our project has the potential to
substantially advance genomic editor delivery to the pulmonary system. These innovations could reconfigure
therapeutic strategies for CF and other genetic diseases caused by nonsense mutations. The feasibility of this
high-impact work is reinforced by our lab's established expertise in these technologies, making it a viable
candidate for significantly advancing the nonviral delivery of genomic medicines and thereby enhancing the
therapeutic options for a wide array of lung diseases.

Public health relevance
SPECIFIC AIMS Current therapies for cystic fibrosis (CF) are insufficient for a large segment of American patients, particularly those harboring CFTR nonsense mutations (NMs). This gap in treatment options signifies a critical unmet medical need, as these mutations represent the most common genetic variants causing CF, yet remain largely unaddressed by existing therapies. To address this therapeutic void, we aim to develop a non-viral base-editing approach specifically designed to correct such mutations. Specific Aim 1: In Vitro Optimization and Characterization of RNA-Encoded ABE Systems This aim focuses on the refinement and characterization of RNA-encoded Adenine Base Editors (ABEs) for in vitro applications, targeting the G542X mutation in the CFTR gene associated with CF. Sub-aim 1.1 is devoted to the synthesis and optimization of chemically modified ABE mRNA to enhance its stability and cellular uptake. Sub-aim 1.2 aims to fine-tune guide RNA (gRNA) configurations to maximize base-editing efficacy while minimizing off-target risks. Sub-aim 1.3 explores the functional recovery of CFTR post-base editing. Utilizing the 16HBEge CFTR G542X cell line as our disease model, we will employ the second-generation PAM-less Cas9 variant, CE-8e-SpRY, which has shown superior performance in preliminary studies. Various methodologies, such as in vitro transcription, gel-based cleavage, and Ussing Chamber assays, will be implemented for comprehensive validation. Specific Aim 2: Development and Screening of LNPs for Pulmonary Delivery of ABE Systems The objective of this aim is to engineer optimized lipid nanoparticles (LNPs) for efficient pulmonary delivery of ABEs. To address key challenges like mucus barrier penetration and endosomal escape, our approach incorporates a high-throughput combinatorial synthesis (HTCS) platform for formulating a novel library of ionizable lipids. A two-tiered screening process will initially be performed in 2D human bronchial cell cultures, followed by ex vivo validation in air-liquid interface (ALI) 3D cultures. The most promising LNP candidates will undergo in vivo testing in murine models, offering a robust, iterative optimization process. Specific Aim 3: Efficacy and Safety Assessment of ABE LNPs in CFTR G542X Mouse Models The overarching objective of this aim is to rigorously evaluate the efficacy and safety of LNP-encapsulated ABEs in a CFTR G542X mouse model, which faithfully replicates the cardinal features of CF. Leveraging the targeted lung delivery of LNPs, we expect to mitigate the risks of off-target effects compared to systemic delivery. Sub- aim 3.1 focuses on the re-optimization of gRNA sequences for mouse primary lung epithelial cells, evaluating both A>G editing efficiency and edit purity. Sub-aim 3.2 involves intratracheal administration of optimized ABE LNPs at variable dosages, assessing therapeutic impact through nasal potential difference (NPD) and genomic analyses. Sub-aim 3.3 will undertake exhaustive molecular scrutiny of potential off-target editing events, utilizing whole-genome sequencing for definitive verification. Anticipated outcomes include the restoration of functional CFTR protein in over 10% of treated mice with minimal off-target events. In the near term, our research endeavors to offer a transformative base-editing treatment for CF patients harboring the G542X mutation. In the long run, this strategy could extend its applicability to approximately 12% of all inherited diseases caused by NMs, many of which are currently without effective treatments. This would constitute a significant advance in gene therapy for CF, filling a critical gap in patient care while also pioneering techniques in RNA and genome editor delivery systems. Upon successful completion of this research, future work will involve the further optimization of LNP-carrying RNA-encoded ABEs for stability in nebulizers, enhancing the translatability of our approach and potentially catalyzing substantial advancements in American health sciences.